CORE B Symington

SUMMARY
The Molecular Analysis of Genomic Instability Core will perform state-of-the-art assays for program
investigators in the analyses of cytogenetic aberrations, and DNA damage responses and repair. These
analyses will complement sequencing results (e.g., examine repetitive regions that are not covered by DNA
sequencing approaches), and provide experimental validation for recurrent genomic instability and
rearrangements identified using genomic approaches (Core C). In addition, the core will perform cell-based
assays to detect and quantify biomarkers for DNA damage and DNA repair pathways, and measure DNA
repair intermediates. Having a dedicated core for this program is beneficial: 1) for cost effectiveness and 2) for
custom designing the experiments based on specific requirement for each of the projects. By centralizing these
services under the leadership of two experienced investigators, Drs. Lorraine Symington and Shan Zha, the
Core will enhance the productivity of the program project members by providing essential services to all
projects, and ensure uniformity of data acquisition and interpretation. The core has two independent specific
aims, which are built upon the expertise of the core leaders. The purpose of Aim 1 is to develop and perform
cytogenetic assays to characterize chromosomal breaks, translocations and copy number changes by
standard G-band karyotyping, spectral karyotyping (SKY), chromosomal painting and locus-specific FISH. In
the second aim, the Core will provide services for automated imaging of DNA damage and response factors,
and will apply quantitative PCR-based assays for detection of ssDNA formed by end resection of site-specific
DSBs in yeast and mammalian cells, and DNA combing method to measure the length of resection tracks on
single molecules from cells treated with irradiation or topoisomerase inhibitors.

Public health relevance
NARRATIVE The Molecular Analysis of Genomic Instability Core will perform state-of-the-art assays for program investigators in the analyses of chromosome aberrations, and the cellular response to DNA damage. Having a dedicated core for this program is beneficial: 1) for cost effectiveness and 2) for custom designing the experiments based on specific requirement for each of the projects. By centralizing these services under the leadership of two experienced investigators, Drs. Lorraine Symington and Shan Zha, the Core will enhance the productivity of the program project members by providing essential and customized services to all projects, and ensure uniformity of data acquisition and interpretation.